Genetic Regulation of Inner, Middle and Outer Ear Development

PROJECT SUMMARY
The mammalian inner, middle and outer ears have different embryonic origins, yet the development of
each component of the auditory apparatus must be precisely synchronized in space and time. Understanding
the mechanisms that regulate and co-ordinate the development of these structures is of central importance in
understanding the basis of the many birth defects that affect hearing. We have identified a Forkhead
transcription factor, Foxi3, that is expressed at very early stages in the embryonic head. Foxi3 mouse
mutants made in our lab lack all components of the inner, middle and external ears. Our work suggests
that one of the first steps in ear induction– the formation of the otic placode – does not occur in Foxi3 mutants.
Moreover, the mesenchyme of the first and second branchial arches that generate the middle ear ossicles and
the external ear begins to form in Foxi3 mutants, but rapidly succumbs to massive cell death. Moreover, we
have recently identified human patients with Foxi3 variants that have a variety of defects in their hearing
apparatus
To our knowledge, Foxi3 is the only mammalian gene that causes a complete developmental failure of the
entire inner, middle and outer ears when mutated by itself. We are therefore extremely interested to
understand how Foxi3 orchestrates development of the auditory apparatus at both the cellular and molecular
levels. Our data suggests that Foxi3 may act as a “pioneer” transcription factor – its main function in addition to
initiating transcription is to epigenetically organize genomic loci containing ear-specific genes in a
transcriptionally competent state. Our first two aims will determine the function and mechanism of Foxi3 during
development of the inner ear using knockout mice, chick embryo manipulations and state-of-the-art ES cell
models, deep sequencing and bioinformatic analysis. Our final aim focuses on the function the Foxi3 gene in
the development of the middle and external ear – here we will both study the effects of loss of Foxi3 in mice,
but also create mouse mutants that recapitulate the genetic variants seen in some of our human patients.

Public health relevance
PROJECT NARRATIVE 1 in 1000 children are born with some form of inherited hearing loss. We have identified gene, Foxi3, that is activated very early in the development of the ear and causes a severe disruption of the inner ear, middle ear and external ear when mutated. We believe that understanding the function of this gene may help to shed light on the causes of human birth defects.